The short and long-term dynamics of opioid/stimulant use: Mixed methods to informoverdose prevention and treatment related to polysubstance use

Project Summary. Overdose deaths surpassed 100,000 in the United States in 2020. While opioid-related
deaths largely attributable to fentanyl continue to rise, deaths involving stimulants, including cocaine, have
increased by over 300% since 2013. A growing driver of the continued overdose crisis in the US is the role of
concurrent use of multiple substances. Although there are pharmacological treatments to address opioid use
disorder, few evidence-based options are available for addressing concurrent stimulant use among people
using opioids. Understanding the dynamics of polysubstance use, particularly opioid and stimulant co-use, and
the role of treatment with respect to the dynamics of co-use, is critical to inform ongoing overdose prevention.
Yet, there are major gaps in our knowledge regarding the patterns and trajectories of opioid and stimulant co-
use and their role in overdose. There is an urgent need to characterize the longitudinal nature of polysubstance
use, treatment utilization, and overdose in community-based samples. The overarching objective of this
proposal is to further our understanding of both long- and short-term patterns of opioid/stimulant use and
examine the longitudinal relationship between co-use of opioids/stimulants and substance use treatment and
non-fatal and fatal overdose over time, in order to inform treatment and overdose prevention services. We
propose the following three specific aims: 1) To characterize long-term patterns of opioid and stimulant co-use
and examine the relationship between trajectories of co-use, substance use treatment, overdose and mortality;
2) To examine real-time short-term patterns and transitions in and out of opioid and stimulant co-use and their
association with substance use treatment and overdose; and 3) To assess opportunities and readiness for
expanding and strengthening service capacity related to treatment and overdose among those with different
patterns of opioid/stimulant use. To achieve these aims, we will leverage over 30 years of behavioral,
laboratory and clinical data from among over 5,000 people who inject drugs within the AIDS Linked to the
IntraVenous Experience (ALIVE) cohort to examine long-term trends and the social determinants of concurrent
opioid/stimulant use. Supplemented with new recruitment of the Stimulant Opioid Non-Injection Cohort
(SONIC), we will conduct new ecological momentary assessments in both samples to examine micro-patterns
of use and employ state-of-the-art machine learning methods to identify patterns and their association with
treatment and overdose over time in this community-based sample at high risk of overdose. Qualitative
research with stakeholders and people with differing patterns of opioid/stimulant co-use will highlight gaps and
challenges within the service system and identify specific implementation strategies to increase capacity to
address heterogeneous concurrent opioid/stimulant use and related needs. The results of this study will
provide evidence to inform intervention and policy to improve outcomes for people who use multiple
substances with the goal of reducing overdose deaths in the US in the context of synthetic opioids.

Public health relevance
Project Narrative This research is relevant to public health because understanding the short- and long-term patterns of concurrent opioid and stimulant use, treatment for substance use disorder, and their impact on overdose will inform overdose prevention efforts and other interventions to mitigate the worsening opioid crisis in the United States. This research is in line with NIH’s HEAL (Helping to End Addiction Long-term) priorities to improve treatment for opioid misuse and addiction and is responsive to RFA-22-047 with an explicit focus on understanding the dynamics of polysubstance use. This mixed methods project will provide the foundation for applied intervention approaches that build on a rich understanding of polysubstance use patterns, trajectories and risk of fatal and non-fatal overdose.